Administrative Supplement: A Profile of Spatial Abilities in People with Down Syndrome and Their Correlations with Everyday Behavior

This is an application for an administrative supplement. The following documents are not
required for submission:
 Project Summary/Abstract


Public health relevance
This is an application for an administrative supplement. The following documents are not required for submission:  Project Summary/Abstract  Project Narrative